MONITORING RECOVERY PLATELET FUNCTION AFTER TERMINATION OF ABCIXIMAB

To identify the optimum index for monitoring the recovering of platelet function after termination of abciximab infusion. Platelet function will be assessed by platelet-dependent hemostasi, platelet aggregation, platelet GP IIb/IIa receptor occupancy and platelet agglutination on fibrinogen-coated beads.